Ecosystem for Multi-modal Brain-behavior Experimentation and Research (EMBER)

PROJECT SUMMARY
Neuroscience research has historically relied on observing tightly controlled behaviors in siloed laboratory
experiments, constraining our understanding of the neural bases of complex behaviors observed in naturalistic
settings. With ongoing advances in unobtrusive sensing technology, artificial intelligence, and machine learning
(AI/ML), and availability of computing power, the field of neuroscience has been afforded an opportunity to make
large-scale discoveries hitherto unimaginable. For this to be realized, however, it is crucial to facilitate secondary
analyses that cut across individual datasets, allowing for research that transcends individual project designs.
Such a goal cannot be achieved without a data archive that provides a compelling technical solution for storing
and curating datasets, and that provides close integration with analytical resources that require minimal technical
expertise to be leveraged.
Here, we propose the Ecosystem for Multi-modal Brain-behavior Experimentation and Research (EMBER), a
data archive specifically tailored to serve the unique needs of the Brain Behavior Quantification and
Synchronization (BBQS) research community, which will be at the forefront of advancing neurobehavioral
knowledge in coming years. At the heart of EMBER is a scalable, hybrid data archive which will house and
manage multimodal and multi-species data collected by diverse research groups. Crucially, our hybrid
architecture will not only automatically execute the optimal storage scheme for different modalities of data,
leveraging existing BRAIN Informatics resources, but also achieve dual objectives of ensuring the security of
behavioral and environmental data — which may include Protected Health Information (PHI) and Personally
Identifiable Information (PII) — as well as expediting querying and data access not only within BBQS datasets
but also with other BRAIN resources. Different cadres of EMBER users, such as BBQS data generators,
analysts, as well as the broader neuroscience community will be able to ingest, curate, and instigate discovery
from data using a user-friendly portal that will streamline highly technical data harmonization and synchronization
steps. In particular, development, testing, and deployment of analysis tools will be supported by cloud-based
sandboxes that are seamlessly integrated with ML/AI resources developed by the BBQS Data Coordination and
Artificial Intelligence Center (DCAIC).
Integral to EMBER’s success will be acceptance in the community as the gold-standard engine for discovery,
providing utility beyond being simply a passive, program-mandated data archive. Throughout its lifecycle, we will
nurture bidirectional collaboration with the data generators, analysts, as well as the broader neuroscience
research community to introduce and maintain tools for sharing, querying, and analyzing data. We anticipate
that EMBER and associated data resources will maximize the BBQS program’s potential to reach its ambitious
objectives of transforming our understanding of the link between brain and behavior.

Public health relevance
PROJECT NARRATIVE We propose the Ecosystem for Multi-modal Brain-behavior Experimentation and Research (EMBER), an accessible and versatile data archive for storage, processing, and curation of multimodal neurophysiological and behavioral datasets. EMBER extends established BRAIN Initiative data infrastructure, provides new data harmonization and synchronization capabilities, and supports scalable integrations for data coordination and AI driven batch processing to enable the goals of the Brain Behavior Quantification and Synchronization (BBQS) program. This resource, developed in close collaboration with BBQS consortia, will facilitate dataset sharing, cross-modality querying, and data mining to fundamentally transform our understanding of cognition and behavior and provide a foundation for improved health and clinical outcomes.